AFRPS Maintenance

Project Summary/Abstract
The Pennsylvania Department of Agriculture, Bureau of Plant Industry promotes feed and food
safety through compliance education, enforcement of rules and regulations, investigation of
feed-related complaints, routine sampling of animal feeds and routine inspection of feed
facilities.
Based on the Department’s Bureau of Plant Industry’s AFRPS Maintenance track, the feed
program needs for the cooperative agreement include:
1. Continue to evaluate the Feed Program’s legal authority to ensure the protection
of the health of man and animals. Evaluate the possibility of updating the Commercial
Feed Act.
2. Maintain and enhance the inspector training course curriculum, supporting the AFRPS
requirements and the needs of our risk-based inspection program to ensure the
knowledge, skills and abilities of feed inspection staff.
3. Maintain and enhance our Esri ArcGIS based Survey 123 to update a risk-
based inspection workplan and adequate inspection and investigation protocol.
4. Maintain a means to evaluate our feed inspection training competencies, for both field
and inspection report procedures, to verify the effectiveness of our training curriculum.
5. Maintain a means to communicate with other agencies and a way to
disseminate information in times of feed-related emergencies and cross-sector events.
6. Maintain written policies and procedures that outline our Feed Program’s enforcement
strategies. Update as necessary.
7. Create and launch statewide educational outreach about feed topics which incorporates
training activities and open communication between regulators, industry, academia and
the consumer.
8. Maintain a means to evaluate the necessary resources to perform routine feed work
in order to assure the Feed Program has adequate support to meet the goals of
the workplan.
9. Continue to evaluate the procedures for sample collection to ensure alignment
with the Feed Program’s priorities.
10. Ensure the alignment of the laboratory procedures with the Association of American
Feed Control Officials (AAFCO) Quality Assurance/Quality Control guidelines and meet
the managerial and technical requirements of ISO/IEC 17025 in order to guarantee valid
and defensible laboratory testing data to protect the health of man and animals.
11. Maintain and operate a review system to ensure periodic assessment of the feed
program per each Standard in order to implement necessary improvement.
The implementation and continuous improvement of the feed program and laboratory plans and
procedures through the AFRPS will assist both Pennsylvania and the Food and Drug
Administration (FDA) to better direct regulatory activities toward preventing feed manufacturing
compliance issues and increasing food safety in the United States.

Public health relevance
PA Department of Agriculture Project Narrative- PAR-20-132 Advance efforts for a nationally integrated food safety system by strategically enhancing our state feed safety program through the maintenance funding of the Animal Feed Regulatory Program Standards (AFRPS). By maintaining implementation of these program standards, the PA feed regulatory program can direct regulatory activities toward preventing animal feed safety hazards and responding to animal feed consumer complaints, recalls, investigations, and strategic risk planning surveillance. By maintaining the AFRPS, the animal feed program will be positioned to both lead or assist federal and other state agencies with emerging or present food safety issues. Project will be managed by Erin Bubb and David Dressler, both, full-time management.